Administrative Core

ABSTRACT – CORE A (ADMINISTRATIVE CORE)
The overarching goal of the Administrative Core is to provide the operational support necessary to successfully
achieve the goals we have laid out for each project and program as a whole. The Administrative Core will be
responsible for managing, coordinating, and monitoring overall progress, and supervising the entire range of the
program's activities. Moreover, the Administrative Core will distribute results to scientific audiences and the
general public and interact with other awarded research programs. We will maximize efficiency, cost-effectiveness, and productivity by centralizing resources used by each of the projects and core. Core personnel
include the Core Lead and a Program Manager. The Administrative Core has the following specific aims: (1)
provide operational oversight and integration of projects and cores, (2) monitor the progress of each of the
research projects and their interactions and promotion of effective collaboration and communication, (3) provide
fiscal administration and compliance, and (4) broadly disseminate results. The organization of the Administrative
Core will have clear lines of authority and will leverage both an Executive Committee and a Scientific Advisory
Committee to ensure effective use of resources, scientific guidance and evaluation, and clear decision-making
processes. Overall, the Administrative Core will provide fully integrated administrative services for the
management, communications, coordination, and financial administration of this U19.